Role of hypothalamic SH2B1 neurocircuits and SH2B1 signal transduction pathways in obesity and metabolic disease

Abstract (Description)
SH2B1 is an adaptor protein that mediates signal transduction in response to a range of ligands, including
brain-derived neurotrophic factor (BDNF). SH2B1 defends against energy imbalance and obesity in both
humans and mice. We reported that systemic deletion of Sh2b1 results in obesity and type 2 diabetes in mice.
Neuron-specific restoration of SH2B1 completely rescues the obesity phenotype in Sh2b1-null mice. We
attempted to identify SH2B1-expressing neurons that control body weight and metabolism. The paraventricular
hypothalamus (PVH) has long been recognized as a key brain center to control energy balance, body weight,
and metabolism. In the preliminary study, we found that PVH neuron-specific deletion of Sh2b1 causes obesity
and metabolic disorders. We observed that a subset of SH2B1 neurons in the PVH (PVHSH2B1) project to the
dorsal raphe nucleus (DRN). The DRN emerges as an important hub of the energy balance neural network.
The DRN houses serotonergic (DRN5-HT), glutamatergic (DRNVglut3), and GABAergic (DRNVgat) neurons. DRN5-
HT and DRNVglut3 neurons suppresses appetite and food intake, whereas DRNVgat neurons have the opposite
effects. However, upstream neurons, which shape the metabolic function of DRN neurons, remain elusive.
Remarkably, optogenetic stimulation of PVHSH2B1 fibers in the DRN suppressed food intake. Deletion of Sh2b1
in DRN-projecting PVHSH2B1 neurons also resulted in obesity. These results define a novel PVHSH2B1→DRN
energy balance circuit. At the molecular level, SH2B1 binds to BDNF receptor TrkB and enhances BDNF/TrkB
signaling. We observed that ablation of SH2B1 in PVHSH2B1 neurons induced BDNF resistance in the PVH. We
also observed that high fat diet (HFD) feeding substantially increases Ser phosphorylation of SH2B1 (pSer157)
in the hypothalamus. These results raise the possibility that Ser phosphorylation may impair the ability of
SH2B1 to safeguard the PVHSH2B1→DRN circuit. Based on these findings, we hypothesize that PVHSH2B1
neurons send monosynaptic outputs to DRN5-HT, DRNVglut3, and/or DRNVgat neurons to shape their activation.
DRN5-HT, DRNVglut3, and/or DRNVgat neurons act downstream to mediate SH2B1 protection against energy
imbalance and obesity. The BDNF/TrkB/SH2B1 pathway cell-autonomously and critically regulates the ability
of PVHSH2B1 neurons to control the behavior of DRN5-HT, DRNVglut3, and/or DRNVgat neurons. Obesogenic factors
impair the PVHSH2B1→DRN energy balance circuit by stimulating, at least in part, Ser phosphorylation of
SH2B1 in PVHSH2B1 neurons. We will test the hypothesis in three aims. Aim 1 will determine whether
PVHSH2B1→DRN5-HT, DRNVglut3, and/or DRNVgat circuits mediate SH2B1 protection against obesity. Aim 2 will
determine whether PVHSH2B1 neuron-intrinsic SH2B1 safeguards, via the BNDF/TrkB/SH2B1 pathway,
PVHSH2B1→DRN circuit functions. Aim 3 will determine whether SH2B1 Ser phosphorylation and human
obesity associated SH2B1 variants in PVHSH2B1 neurons promote obesity.

Public health relevance
Project Narrative (describe the relevance of this research to public health in no more than 3 sentences) This project will map brain SH2B1 neurocircuits and investigate how defects cause obesity, type 2 diabetes, and fatty liver disease. We will utilize innovative genetic models, neuroscience techniques, and physiological approaches to study SH2B1 neurocircuits and functions. The outcomes of this project are expected to develop a new treatment strategy for obesity and type 2 diabetes by therapeutically targeting SH2B1 neurocircuits and SH2B1 signal transduction pathways.